Pathophysiology of insulin-regulated renal blood flow and sodium excretion

Project Summary/Abstract
Impaired regulation of renal blood flow (RBF) is recognized as a critical element in the pathologies of diabetes
and metabolic syndrome through effects on glomerular pressure, GFR, and urinary sodium excretion (UNaV).
The mechanism for impaired RBF regulation in these conditions is not known. We have evidence for a novel
physiological effect of insulin on RBF that may translate to mechanisms for pathophysiological RBF impact.
Our data suggest that preventing excess sodium loss after meals is the physiological function of insulin-
regulated UNaV. This is not due solely to tubular sodium reabsorption, as the literature would predict. We
show that insulin also exerts renal vasoconstrictor tone after meals, possibly via thromboxane (TXA2), that
limits the degree of meal-induced renal vasodilation. Impairment, of that physiological function should cause
excessive renal vasodilation after meals, causing renal salt wasting and potential long-term implications on the
progression of CKD. Exaggeration of this physiological function should cause overt renal vasoconstriction,
sodium retention, and hypertension if sustained. Additional data show that blocking the protective role of
nitric oxide (NO) enables high-sucrose diet to cause hypertension, which we can prevent by blocking
hyperinsulinemia. We will test the central hypothesis that: The physiological, sodium-conserving effect of
insulin is mediated in part by a post-meal renal vasoconstrictor influence that limits the degree of meal-induced
renal vasodilation. Counterbalancing input from nitric oxide is required to prevent overt renal vasoconstriction
and hypertension. The specific aims will test whether:
Aim 1: The physiological, sodium-conserving effect of insulin is mediated in part by a post-meal renal
vasoconstrictor influence. The experiments will test the hypotheses that: a. Preventing the meal-induced
increase in plasma insulin will cause greater and more sustained increases in RBF and greater UNaV than
occurs in normal control rats. b. The insulin-dependent renal vasoconstrictor influence requires TXA2. c. Under
conditions of background NOS inhibition, glucose bolus will cause overall renal vasoconstriction and amplified
sodium retention. d. ENaC mediates the tubular reabsorption component of the acute sodium-conserving
effect of insulin. Aim 2: Impaired NO synthesis causes insulin-dependent renal vasoconstriction and
hypertension during high-sucrose intake. Experiments test the hypotheses that: a. NOS inhibition will enable
chronic high-sucrose intake to cause hypertension (DSI telemetry, 24 hr/day). b. Blocking hyperinsulinemia will
prevent the hypertensive response to high-sucrose intake. Restoring only intra-renal hyperinsulinemia
restores the hypertension response. c. TXA2 synthase inhibition will prevent the hypertensive effect of chronic
high-sucrose intake.

Public health relevance
Narrative Although Insulin is well-known to stimulate renal sodium transport, neither the physiological function of this action, nor direct, cause-effect evidence that it causes hypertension, have been described. We have new evidence for renal blood flow regulation by insulin as a novel mechanism for insulin-regulated urinary sodium excretion. This not only has implications for progression of CKD in diabetes, but these studies also will reveal mechanisms that translate insulin's physiological, sodium-conserving role into a mechanism for chronic hypertension in metabolic syndrome.